Mechanistic Basis for Non-Canonical Translation in Neurological Disease

Project Summary
CAG repeat expansion diseases are the most common class of microsatellite expansion disorders. While
canonical translation of the CAG repeat leads to the production of polyglutamine proteins, these expansions can
also undergo non-canonical repeat associated non-AUG (RAN) translation. In the later process, translation is
initiated across multiple reading frames in the absence of AUG- or AUG-like start codons. While a few factors
that influence either canonical translation across microsatellite expansions or RAN translation have been
identified, our understanding of the underlying molecular mechanisms responsible for translation in multiple
reading frames is extremely limited. Despite evidence that RNA structure plays a key role in RAN translation our
knowledge of the structural features that facilitate RAN translation is extremely limited. To examine the role of
RNA structure in non-canonical translation, I used a structure-forward approach to screen for multi-frame
translation, through which I identified several long non-coding RNAs (lncRNAs) that support translation in
multiple reading frames in the absence of both microsatellite repeat expansions and AUG-start codons. This
data suggests multiple avenues for RNA transcripts to support multi-frame translation, which has important
implications in biology, disease, and therapeutics. The overarching goal of this proposal is to determine the RNA
structures, protein networks and therapeutically relevant modifiers that govern various forms of multi-frame
translation (MFT). To determine the proportion of the human genome capable of undergoing MFT, I will utilize a
novel MFT reporter system to perform a genome-wide screen. Utilising candidate MFT sequences and CAG
repeat expansions along with my already identified MFT lncRNAs, I will determine the cellular RNA structures
and protein factors that facilitate non-canonical multi-frame translation. I will also employ a first-of-its-kind
strategy to identify novel, therapeutically relevant modifiers of co-occurring canonical and non-canonical
translation in multiple reading frames. These studies will enable a better understanding of the mechanism of
multi-frame translation and identify therapeutic strategies that have the potential to provide therapeutic efficacy
across multiple CAG repeat expansion diseases and be applicable to a wider range of neurological diseases.
Together this research provides an innovative approach to understand a novel paradigm for translation diversity
and will enable a better understanding of disease pathogenesis in repeat expansion diseases as well as
elucidating the aspects of MFT most suitable to therapeutic intervention.

Public health relevance
Project Narrative There is a growing interest in the different types of non-canonical translation, including repeat associated non- AUG translation which is associated with RNA structure, translation in multiple frames and microsatellite expansion diseases. Having identified other forms of multi-frame non-canonical translation outside of RAN translation, the overarching goal of this proposal is to determine the RNA structures, protein networks and therapeutically relevant modifiers that govern different types of multi-frame translation. Together this information will provide a deeper understanding of the mechanism of multi-frame translation and the processes that govern human cellular proteome diversity, which in turn will enable informed therapy development across multiple microsatellite expansion diseases.